Evaluating the HITSystem to Improve PMTCT Retention and Maternal Viral Suppression in Kenya

Summary/Abstract
The candidate for this diversity supplement is Christina M. Pacheco, JD, MPH, an American Indian (Cherokee
and Quechua) - Latina (heritage from Bolivia) researcher and faculty member at The University of Kansas
Medical Center (KUMC). As an early career investigator, long-term career goal is to become a
fully independent investigator in public health research, obtaining a tenure track faculty position, and continuing
her efforts to address health inequities among global populations by making major contributions to public health.
Specifically, her goal is to develop, implement and evaluate culturally tailored interventions/strategies that
address individual, social, political, cultural and environmental factors that contribute to health inequities among
global underserved/historically resilient populations and to translate those results into support for health policies.
The goals of this supplement are for Ms. Pacheco to 1) Receive training in implementation science as it relates
to the theories and methods relevant to design strategies to facilitate health intervention uptake and
sustainability, 2. Increase her knowledge about the global factors (social/cultural, political, environmental, etc.)
impacting implementation of proven cost-effective interventions at different stake-holder levels, in varied
resource settings, and 3. Establish a track record of scholarly publications and enhance her grant writing so that
she can launch an independent research career with global underserved/ historically resilient populations. She
will accomplish these goals under the mentorship of Drs. Sarah Finocchario Kessler, Ed Ellerbeck and Ms. May
Maloba and by joining the team of American and Kenyan researchers on the parent R01, taking the lead on a
sub-project contained within the scope of the parent grant, completing formal courses and seminars, publishing
her work, and presenting at national conferences to build her skills and research network.
The proposed research experience of this diversity supplement will be an integral component of the parent R01,
which evaluates the efficacy of the HIV Infant Tracking System (HITSystem) 2.1 to increase the complete
prevention of mother-to-child transmission retention with guideline-adherent services and to increase viral load
suppression and appropriate clinical action through the extended period of 6 months postpartum. Ms.
Pacheco’s sub-study will build on the parent grant’s understanding of the implementation of the HITT System
cost-effectiveness. The research aims of this supplement are to:
1. Conduct 34 interviews with key stakeholders at the national (n=4), county (n=6), and hospital- level
(n=24) to gather feedback on implementation considerations for HITSystem scale up.
2. Based on data from key stakeholder interviews, develop and refine 3-4 implementation strategies
(e.g., use of a clinic champion, incentivizing use of HITSystem, etc.) for varied resource settings.
Refinement will be done using a Delphi method.

Public health relevance
Project Narrative The University of Kansas Medical Center is proud to support a NIMH Diversity Supplement application to the parent grant Evaluating HITSystem 2.1 to Improve Viral Suppression in Kenya (R01MH121245) to support Christina M. Pacheco , JD, MPH, goal of becoming an independently funded researcher Developing Independent Research Careers. The goals of this supplement are for Ms. Pacheco to 1) Receive training in implementation science as it relates to the theories and methods relevant to design strategies to facilitate health intervention uptake and sustainability, 2) Increase knowledge about the global factors (social/cultural, political, environmental, etc.) impacting implementation of proven cost-effective interventions at different stake-holder levels, in varied resource settings, and 3) Establish track record of scholarly publications and enhance grant writing to launch an independent research career with global underserved/ historically resilient populations. This supplement will allow Ms. Pacheco to expand her knowledge of the non-financial drivers impacting implementation of proven cost- effective interventions at different stakeholder levels, in varied resource settings. She will accomplish these goals under the mentorship of Drs. Sarah Finocchario Kessler (parent grant PI and Lead Mentor) and Ed Ellerbeck (implementation scientist and co-Mentor), and May Maloba (parent grant Co-I and co-Mentor) taking the lead on a sub-project contained within the scope of the parent grant, completing formal courses and seminars, and presenting at national/international conferences to build her skills and research network.